Enhanced Surveillance for New Vaccine Preventable Diseases

Enhanced Surveillance for New Vaccine Preventable Diseases Project Summary Children's Mercy Hospitals and Clinics (CMH), located in Kansas City, MO. is a large, comprehensive pediatric medical center and the only free standing children's hospital between St. Louis and Denver. CMH provides state-of-the-art care for children from 18 primary counties in Missouri, Kansas and adjoining areas with a total population approaching 2.5 million. In 2009 CMH established an active population-based surveillance system through Centers for Disease Control and Prevention (CDC) funding mechanism from American Recovery and Reinvestment Act. The CMH active surveillance system can be effectively utilized to study the impact of new or upcoming vaccines and policies relating to vaccination. Our active surveillance system will monitor community rates of acute gastroenteritis (AGE) and acute respiratory illness (ARI) by prospectively enrolling children year-round in both our outpatient and inpatient locations. Our two model projects are described below: First model project: Our first model project will examine rotavirus vaccination effectiveness through population-based, laboratory confirmed, active surveillance. Specifically, we will prospectively monitor rotavirus disease burden and characterize rotavirus genotypes. Parents of the AGE children and control subjects will be consented to participate in the study; a stool specimen (only for AGE children) and permission to access vaccination record will be requested. Stool specimen is tested in CMH laboratory for rotavirus antigen and positive specimens will be shipped to CDC for genotyping. Rotavirus vaccination record will be accessed through Kansas and Missouri vaccination registries, CMH electronic medical records or by contacting primary care provider. Rotavirus vaccine effectiveness will be calculated by comparing rotavirus positive to rotavirus negative or control children. Second model project: The goal of our second model project is to understand the epidemiology of human parechovirus (HPeV) associated AGE. HPeV is a newly described virus closely related to enterovirus (EV). The majority of the newly described HPeV types (17 types) have been isolated from diarrheal stool specimens obtained from children around the world. HPeV is also associated with respiratory illness and central nervous system infection in infants. The evaluation of the burden of HPeV associated infections in the US currently is limited to a passive surveillance system and a few ad hoc studies in academic centers. We have recently demonstrated a high burden of HPeV3-CNS infections (18%) in US children during 2007 and 2009 (Selvarangan et al 2010; appendix 3). The proposed NVSN network can be effectively utilized to understand the epidemiology of this newly recognized viral pathogen. The specific questions we can address include: • Incidence of HPeV in diarrheal and respiratory stool specimens in children • Clinical presentation associated with HPeV infections • Discovery of new HPeV types in collaboration with CDC, Picornavirus laboratory • Association of currently circulating HPeV types with specific illnesses CMH's previous success enrolling subjects in NVSN demonstrates our capabilities. Notably, CMH has the flexibility and capability of extending surveillance to other vaccine preventable diseases, demonstrated ability to collect stool specimens and rotavirus vaccination data on subjects enrolled in the study, ability to access hospital admission data, and two years of rotavirus surveillance data from our participation in NVSN.

Public health relevance
Project Narrative The Children's Mercy Hospital population-based active surveillance system is engaged in evaluation of the impact of new or upcoming vaccines. Real-time surveillance data generated from our surveillance efforts will allow us to better understand the epidemiology of new and emerging gastrointestinal and respiratory pathogens targeted for control through vaccination practices. __SpecificAimsTextDelimiter__ Specific Aims Acute gastroenteritis (AGE) and acute respiratory illness (ARI) are two of the leading causes of infectious diseases in children. They cause significant morbidity in the developed world and mortality in the developing world. Advances in medicine have produced effective vaccines for some of the leading causes of AGE and ARI. Development of current and future vaccines and implementation of ongoing vaccination programs require knowledge of quantity/severity of the disease burden, the socioeconomic impact of disease, and definition of variability within strains of the targeted pathogen. From these data, careful efficacy/cost/benefit analyses are developed to finalize recommendations for vaccine development. Once implemented, vaccine initiatives require ongoing surveillance to ensure an understanding of real-world efficacy and vigilance against strain, serotype, or type replacement; a process wherein vaccine strains are replaced with non vaccine strains that previously were minor players in disease. Active population based surveillance for infectious disease is a proven methodology to study the epidemiology of infections in the community both before and after vaccine distribution. An active surveillance network can be utilized to gain an understanding of the real burden of the infectious disease, to collect data on new vaccine use, to determine the impact of new and upcoming vaccines, and to evaluate vaccination policies. Children's Mercy Hospital (CMH) established a population based active surveillance program in 2009 through funding from Centers for Disease Control and Prevention. The active surveillance system initially established at CMH, its team of investigators and accompanying infrastructure can be effectively utilized to study the impact of new or upcoming vaccines and policies relating to immunization. Our active surveillance system will monitor community rates of AGE and ARI by prospectively enrolling children year-round in both our outpatient and inpatient locations. Our two model projects are described below: 1. To evaluate rotavirus vaccine effectiveness by a prospective, population based active surveillance system. 2. To understand the epidemiology of Human parechovirus virus associated gastroenteritis in US children. First model project: Our first model project will examine rotavirus vaccination effectiveness through population-based, laboratory confirmed active surveillance. Specifically, we will prospectively monitor rotavirus disease burden and characterize rotavirus genotypes. Parents of the AGE children and of control subjects will be consented to participate in the study; a stool specimen (only for AGE children) and permission to access vaccination record will be requested. Stool specimens will be tested in the CMH laboratory for rotavirus antigen and positive specimens will be shipped to CDC for genotyping. Rotavirus vaccination records will be accessed through Kansas and Missouri vaccination registries, CMH electronic medical records or by contacting primary care provider. Rotavirus vaccine effectiveness will be calculated by comparing rotavirus positive to rotavirus negative or control children. Second model project: The goal of our second model project is to understand the epidemiology of human parechovirus (HPeV) associated AGE. HPeV is a newly described virus closely related to enterovirus (EV). The majority of the newly described HPeV types (17 types) have been isolated from diarrheal stool specimens obtained from children around the world. HPeV is also associated with respiratory illness and central nervous system infection in infants. The evaluation of the burden of HPeV associated infections in the US currently is limited to a passive surveillance system and a few ad hoc studies in academic centers. We have recently demonstrated a high burden of HPeV3-CNS infections (18%) in US children during 2007 and 2009 (Selvarangan et al 2010). The proposed NVSN network will effectively determine the epidemiology of this newly recognized viral pathogen. The specific questions we will address include: • Incidence of HPeV in diarrheal stool specimens in children • Clinical presentation associated with HPeV infections • Discovery of new HPeV types in collaboration with CDC Picornavirus laboratory • Association of currently circulating HPeV types with specific disease presentations